Personalized Adoptive T-cell Therapy for AML

Abstract/Project Summary
The development of strategies to expand and activate AML specific T cells is of critical importance. We have
developed a personalized cancer vaccine in which patient derived tumor cells are fused with autologous
dendritic cells (DCs), presenting a broad array of antigens that capture the heterogeneity of the leukemia cell
population, including shared and neoantigens. We have completed a phase II clinical trial in which patients that
achieve remission following chemotherapy undergo serial vaccination with DC/AML fusions. Remarkably,
despite a median age of 63, 71% remained free of disease with a median follow up of 5 years. Vaccination was
associated with the expansion of T cells targeting both autologous AML cells and leukemia associated
antigens. The DC/AML vaccine can be used as a platform to generate activated leukemia-specific T cells ex-
vivo for adoptive immunotherapy. In this way, effector cells may be generated that are leukemia specific,
capture tumor heterogeneity, and are activated ex vivo to achieve a functionally competent phenotype. We
have demonstrated that vaccine stimulation in the context of IL7/IL-15 results in enhanced levels of central
memory cells critical for long term persistence of response. While the generation of vaccine stimulated
leukemia specific T cells ex vivo represents a promising strategy to effectively target AML cells in vivo, the
immunosuppressive nature of the tumor microenvironment remains a barrier to the development of a memory
response and long-term protection. We performed transcriptome analysis in the remission bone marrow at
time of vaccination to identify biomarkers that were predictive of durable response as compared to early
relapse following vaccination with DC/AML fusions. Of note, decreased expression of TGF-β in the bone
marrow microenvironment was associated with durable remission. These results are consistent with prior
reports suggesting TGF-β as a negative regulator of tumor immunogenicity, T cell activation and infiltration
into the tumor bed. As such there is strong rationale to target TGFβ to enhance vaccine efficacy. In the
present study, we will create a novel strategy for adoptive T cell therapy generated by vaccine mediated
stimulation, selection of antigen specific T cells and ex vivo expansion. Functional characteristics will be
examined in an immunocompetent murine leukemia model. We will then examine the effect of TGF-β inhibition
on vaccine response and TGF inhibition within vaccine stimulated T cells by silencing of the downstream
effector SMAD2. In the second aim, the T cell product will be characterized with respect to targeting of shared
and neo-antigen targets, oligoclonal expansion and diversity of the repertoire, expression of markers of
activation, exhaustion, senescence, and chemokines needed for migration into the tumor bed. In the third aim,
we will conduct a Phase I study in which patients with AML who achieve complete remission will undergo
adoptive therapy with vaccine stimulated T cells.

Public health relevance
Narrative In the present proposal, we will design a novel combination strategy for vaccine mediated ex vivo T cell expansion that promotes the expansion of central memory cells, enhances the activation and expansion of functionally dominant clones, and reverses critical mediators of the immunosuppressive milieu through TGFβ inhibition. Patient specific DC/AML fusions will be used to interrogate the relative dominance of T cell clones targeting individual neoantigens. In third aim, we will translate the preclinical findings into a phase I clinical trial and study the correlation between the characteristics of the T cell product with toxicity, in vivo activation, expansion, and persistence, and protection from relapse.